Migration and Geographic Inequality in Mid-Life Mortality

PROJECT SUMMARY
Since 2010, we have observed steep increases in geographic inequality in mortality that have been
strongly tied to stalled mortality declines at the prime adult ages (i.e., 25-64). To date, researchers have
analyzed the effects of unemployment, prescription drug monitoring programs, changes in cardiometabolic risk,
cigarette smoking, education, health care access, state policies, and a number of other factors thought to
influence geographic disparities in mortality. One process that has not been examined in relation to rising
geographic inequality in mid-life mortality is migration. Migration has enormous potential to impact geographic
inequalities in mortality since it not only configures the makeup of an area, but also influences the properties of
a place that themselves may impinge on mortality. Thus, this project examines the contribution of international
and domestic migration to levels of and trends in mortality and geographic inequality in mortality. Our analyses
focus on both inequality within the United States and inequality between the U.S. and other high-income
countries. We use vital statistics and census microdata linked to mortality follow-up to assess how international
and domestic migration have direct impacts on mortality inequality by concentrating healthy, low-mortality
migrants in specific parts of the country, and indirect impacts on non-migrant mortality by reshaping the
characteristics of places that have been shown to influence mortality levels. We provide the first subnational
estimates of mortality by nativity and the first estimates for the U.S. of the effects of domestic migration on
geographic inequality in mid-life mortality. Using a quasi-experimental research design, we identify the causal
effect of migration on non-migrants, constituting the first demonstration of the magnitude of spillover effects on
U.S. mortality. While countries differ in their proportions foreign-born and in their migration streams, it is not yet
known how immigration impacts cross-national inequality in mortality. We investigate how international
migration contributes to the U.S. life expectancy shortfall and to variation in mortality across high-income
countries, including in measures of life expectancy, mid-life mortality, and lifespan inequality. An important
byproduct of this project is that we will release a public database of high-quality life tables for the native-born
and foreign-born populations of the U.S. and other high-income countries, as well as a public database of life
tables for the native- and foreign-born populations of geographic areas within the United States. This project
provides new theoretical knowledge of how people and places respond to migration, and of the multiplicity of
dynamic responses of mortality to migration trends. Methodologically, this project builds out a new set of
demographic methods that allow model-based heterogeneous mortality rates to be linked to counties on the
basis of individual and county-level characteristics. It also applies a set of causal methods that have not
previously been used to study mortality in order to model the geographically differentiated spillover effects of
migration on mortality.

Public health relevance
PROJECT NARRATIVE This project examines the role of domestic and international migration in determining area-level mortality rates and geographic inequality in mortality across counties, metropolitan areas, states, and regions of the United States between 1990 and present, as well as cross-national inequalities in mortality among 18 high- income countries. In addition to investigating how low-mortality migrants may decrease average mortality rates of specific areas, we assess how migrants impact the mortality rates of non-migrants by making areas where they settle better places to live. The findings inform our understanding of how policies relating to migration may have short- and long-term effects on place-based health and health inequalities.